Neutrophil Nox2 controls mononuclear cell functions in inflammation; role in CGD

Project Summary / Abstract
Chronic granulomatous disease (CGD) is a rare, but devastating, disease with known genetic abnormalities in
the phagocyte (white blood cell) oxidase. In addition to immunodeficiency (the inability to fight certain bacteria
and fungi), patients with this disease often have complex and poorly understood abnormalities in inflammatory
processes manifest as colitis, poor wound healing, obstructing granuloma, and autoimmunity. Importantly,
there is a lack of clearly applicable and effective treatments for many of these inflammatory consequences.
Our studies in an animal model of human X-linked CGD clearly point to abnormal crosstalk during inflammatory
processes between two different types of phagocytes, both with the mutated oxidase: neutrophils (or
granulocytes) and mononuclear phagocytes. Specifically, we have shown that whereas CGD neutrophils were
unable control the recruitment, maturation, inflammatory programming and disposal of the mononuclear
phagocytes at sites of inflammation, the direct introduction of normal neutrophils was able to restore these
activities and events in vivo. As such, signals from normal neutrophils orchestrate the activities of the
mononuclear phagocytes at each step in the normal development and resolution of inflammation. It is
hypothesized that identifying these signals provided by normal neutrophils could provide new therapeutic
strategies. Using the murine model and adoptive transfers of neutrophils and their products as well as cell co-
culture experiments (ex vivo), this proposal aims to define the mechanisms underlying the abnormal
mononuclear phagocyte behavior in CGD and the precise processes lacking in CGD neutrophils that are
overcome by the addition of normal neutrophils. Defining these is expected to lead to novel approaches to
treatment of CGD and possibly other chronic inflammatory conditions.
.

Public health relevance
Project Narrative: Relevance to Public Health Mutations of the NADPH oxidase found in white blood cells (specifically, neutrophils and mononuclear phagocytes) underlie Chronic Granulomatous Disease (CGD), and patients with this disorder suffer from the inability to fight off infection with certain bacteria and fungi, and also suffer exaggerated inflammation, e.g. poor wound healing, obstructing granulomas, colitis, and autoimmunity. Data in a murine model of CGD show that the absence of oxidase activity in neutrophils leads to failure in the control of recruitment, activities and disposal of mononuclear phagocytes, and conversely, supplying normal neutrophils normalizes these. This proposal aims to determine the mechanisms and identify the precise signals supplied by normal neutrophils that orchestrate `normal' inflammatory activities of mononuclear phagocytes as a means of developing novel therapeutic strategies in this disease.